Epithelial Cell Mechanobiology in Mechanically Heterogeneous Microenvironments

PROJECT SUMMARY
Epithelial tissues are multilayered with varying elasticity and geometry in different layers, e.g., gut epithelium,
lungs, or skin. Cells aggregate or migrate in different regions of tissues, as needed for various biological
demands of disease and development, by sensing and responding to both mechanical and biochemical
properties of their extracellular matrix (ECM). In wound healing, tumor invasion, and embryogenesis, epithelial
leader cells generate mechanosensitive protrusions and coordinate their forces with follower cells for directed
migration to fill gaps and voids in epithelial layers and tissues. This transmission of forces and
mechanotransduction signaling spans across length scales, from cell-ECM adhesions, cell-cell junctions, and
cytoskeletal network into the nucleus. We have shown that epithelial cells mechanosense extracellular matrix
(ECM) stiffness, confinement, and fiber architecture. Building on these classic mechanobiology studies, we
have also shown that epithelial cells store mechanical memory of their past environments, which informs their
future migration and generates matrix memory through active remodeling of 3D collagen microenvironments.
Additionally, disruption of nuclear export imparts concurrent epithelial and mesenchymal states. However,
there are significant gaps in knowledge about how epithelia sense tissue defects and wounds, whether the
force requirement for cell migration changes with environment topography, and how nuclear mechanosensing
causes disorder in epithelia. These gaps in knowledge require novel bioengineering approaches to decouple
these multivariate problems. In this MIRA program, we will study epithelial mechanosensing, response, and
memory in three broad areas. First, we study how epithelial cells sense extracellular wounds of varying
collagen types and matrix stiffness, and how cytoskeletal reinforcement and depth-mechanosensing overcome
and heal ECM wounds. Second, we examine whether the classic force-dependent fast epithelial migration can
occur with lower forces by changing ECM fiber alignment, and how spatiotemporal coordination of extracellular
force transmission and intercellular mechanotransduction governs such force-effective migration. Third, we
connect dysfunctions in nuclear transport and nucleocytoplasmic communication to epithelial disorder,
unjamming, and migration. In these projects, we also ask whether epithelial cells remember their past
extracellular stimuli and whether such memory alters their future response. These projects bring novel
mechanobiology perspectives to conventional epithelial biology and could reveal new responses at different
time and length scales, such as mechanical memory, depth-sensing, and epithelial transitions through nuclear
mechanics. This work employs and nurtures diverse perspectives due to its inherently multidisciplinary
approach in biophysics, engineering, and cell biology. Our results will highlight how the mechanically complex
extracellular environments proactively regulate epithelial mechanosensing and may inform new insights and
therapies for dysfunctional embryonic development, cancer, injury response, and wound healing.

Public health relevance
PROJECT NARRATIVE The basic research proposal will study how epithelia sense and acquire memories of their biochemically and mechanically varying extracellular microenvironments over time. These findings will reveal how epithelial cells ‘mechanosense’ not just environmental stiffness but also aligned fibers and extracellular matrix wounds, and how disruptions in nuclear transport or cytoskeletal connections cause macroscale disorder in epithelia. These novel fundamental insights could potentially inform new therapies for would healing, cancer, fibrosis, and developmental dysfunctions.